Fundamental and applied studies of nucleic acids

Fundamental and applied studies of nucleic acids
For 30 years the Maher laboratory has been investigating unresolved problems in nucleic acids biology and
biophysics. We will continue our collaborative efforts related to two major challenges in the ﬁeld. These
challenges are deliberately diverse and multidisciplinary, spanning fundamental and applied aspects of nucleic
acid structure and function. This work brings unique opportunities for synergy and creates an exceptional
training environment.
Challenge 1: Can principles learned from studies of bacterial DNA looping be applied to artiﬁcial DNA
looping for gene regulation?
Hypothesis 1.1: We hypothesize that small DNA loops form more easily in vivo than in vitro because a)
proteins bridge DNA loops to reduce required DNA bending, b) DNA supercoiling pre-bends DNA, and c)
architectural DNA binding proteins kink DNA. Molecular biology experiments will be performed in vitro and
using elements of the lac operon in living E. coli cells.
Hypothesis 1.2: We hypothesize that designed sequence-speciﬁc DNA binding proteins can be used to create
artiﬁcial gene regulatory loops in bacterial and eukaryotic systems. Our studies will implement novel
Transcription Activator-like Effector (TALE) proteins controlled by chemically-induced heterodimerization to
regulate model and endogenous genes by creating tight DNA loops that exclude RNA polymerase from gene
promoters. This work will impact synthetic biology efforts.
Challenge 2: Can we identify naked DNA aptamers that home to sub-cellular compartments?
Hypothesis 2.1: We hypothesize that the mechanism of nucleus-homing DNA aptamers we previously
identiﬁed using Ligase Proximity Selection can be understood by proteomics and this selection concept
extended to discover naked DNA aptamers that exhibit tissue-speciﬁc nuclear homing in mice.
Hypothesis 2.2: We hypothesize that our new Peroxidase Proximity Selection will identify homing DNA
aptamers speciﬁc for different sub-cellular compartments of interest. We will study peroxidase biotinylation
reward chemistry, undertake selections in live cultured cells, and explore the mechanism of discovered homing
aptamers as possible delivery agents for proteins and drugs.
Support for this proposal will sustain the Maher laboratory's productive research program addressing these two
important and unresolved challenges. The laboratory's track record shows that this investment will trigger
further innovations with impact beyond these two problems.

Public health relevance
Narrative: Fundamental and applied studies of nucleic acids For 30 years the Maher laboratory has been studying how the DNA and RNA molecules in cells work, and how they can be used as tools to do new things. We are learning how these molecules ﬁt inside cells, and how collections of trillions of random DNA and RNA molecules can be used as raw material to discover new drugs. Support for the work of the Maher laboratory promises important new discoveries across a range of ﬁelds, and a challenging research environment ideal for training students.